Foxp3 isoform expression and regulation of autoantibody production

PROJECT SUMMARY
Systemic Lupus Erythematosus (SLE) is a multi-systemic autoimmune disease that arises from a
combination of genetic factors, dysregulated immune responses and environmental triggers. SLE-like
phenotypes, including elevated anti-nuclear IgG autoantibody titers, kidney nephritis, splenomegaly and reduced
survival have been reported in several animal models of SLE, but few of these models require environmental
factors to drive disease. Therefore, studies of causative environmental factors have used mouse models that
already have lethal SLE disease prior to exposure. Consequently, they cannot be used to determine how these
factors can induce flares in patients with latent SLE. Therefore, a mouse model of moderate SLE is required to
appropriately replicate SLE flares that are induced by environmental triggers.
Regulatory T (Treg) cells play a central role in maintaining immune system homeostasis and modulating
immune responses. Foxp3 is a master regulator of Treg development and function. FOXP3 mutations in patients
with IPEX (Immunodysregulation, polyendocrinopathy, enteropathy, X-linked syndrome), which result in a
deficiency in Tregs, result in lethal autoimmunity, similar to the disease observed in Foxp3 deficient mice. While
highly conserved in both amino acid sequence and gene structure, one difference between humans and mice is
that the human FOXP3 gene encodes two major alternatively spliced isoforms: a full-length version that uses
all 10 exons (FOXP3FL, the only isoform in mice) and a shorter isoform lacking exon 2 (FOXP3∆E2). Recent
studies have shown that Tregs from patients with some autoimmune diseases express increased levels of the
∆E2 isoform compared to those from healthy donors. Consistent with this finding, we have found that Tregs from
SLE patients have increased expression of the FOXP3∆Ex2 isoform.
To study the role of the ∆E2 isoform in Treg function we generated a new mouse strain with Foxp3 exon
2 deletion. Interestingly, we found that Foxp3∆E2 mice develop hallmark features of SLE, including anti-DNA
and anti-nuclear autoantibodies, increased number and size of spontaneous germinal centers and kidney
deposition of antibody complexes, by 4-5 weeks of age. Our central hypothesis is that expression of the
∆E2 isoform of FOXP3 leads to Treg dysfunction and loss of tolerance. To test this hypothesis we will first
determine the role of Foxp3∆Ex2-expressing Tregs in germinal center function, focusing on the relationship
between Tfh and Tfr cells. Next, we will assess the response to UVB light in Foxp3∆E2 mice. Finally, we will
examine the expression of FOXP3∆E2 in Tregs from cohorts of SLE and MCTD patients to determine the
potential role of this isoform and disease expression. These studies will provide insights into the role of
Foxp3∆E2 Treg function and predisposition to SLE.

Public health relevance
PROJECT NARRATIVE Autoimmune diseases like Systemic lupus erythematosus (SLE) are characterized by the presence of autoantibodies. We have found that a subset of regulatory cells important for controlling antibody production is dysfunctional in SLE patients, and that the same subset leads to spontaneous lupus-like disease in animal models. In this study we will use this model, as well as SLE samples, to reveal novel pathways for therapeutic intervention.